Use Of Animal Models To Study Genes That Modulate Atherosclerosis

In the past year, we have made several new transgenic mice lines. We made for the first time, using Zinc fingers, apoC-II KO mice to investigate the effect of an apoC-II mimetic peptide that we have developed for lowering serum triglycerides. This mouse also had an unexpected obesity and insulin resistance phenotype, which we plan to investigate in the future. Produced a novel mouse model of over expression of SR-BI in endothelial cells, which protected against diet induced atherosclerosis and was just accepted for publication. Crossed our SR-BI-KO mice with mice either over or under expressing LCAT transgenic mice and showed a positive benefit of increased LCAT activity in reducing diet induced atherosclerosis, which was just accepted for publication.